Mouse Phenotyping Informatics Infrastructure - Data acquisition, integration, analysis and translation of high throughput mammalian phenotyping data.

PROJECT SUMMARY
The International Mouse Phenotyping Consortium (IMPC) is a critical resource for biomedical research
providing novel gene-phenotype associations for genes with little or no known function, supplying strains for
thousands of mechanistic studies and delivering integration with genomic, phenomic and human disease-
relevant information providing improved understanding into the underlying causes of rare and common
disease. This project aims to improve the FAIR-ness and TRUST-worthiness of the resource by:
● Improving resource identification with a focus on the actual model organisms produced by the
consortium
● Increasing the exposure and adoption of the resource by publishing an IMPC knowledge graph
● Developing a proof of concept to capture cost metrics for long-term sustainability

Public health relevance
PROJECT NARRATIVE Understanding human health and disease requires a deep understanding of gene function for all human genes. The lab mouse is genetically very similar to humans and is used to study the causes of common and rare human diseases. We provide access to millions of data points about mice that have had a gene removed and the data analysis discovers new gene functions and improves our understanding of normal and disease processes with the prospect of improving diagnoses for rare genetic disease and illuminating the causes of common diseases such as heart disease.